Task C2: Development of continuous in vitro culture system for Cryptosporidium

This contract provides in vitro testing of potential agents to treat parasites and their vectors, maintenance of parasite and vector stocks, and the development of related assays.